Preclinical Imaging Laboratory Shared Resource

Abstract/Project Summary
PRECLINICAL IMAGING LABORATORY (PCI)
The mission of the Preclinical Imaging Laboratory Shared Resource (PCI) shared resource is to
enable and foster cutting edge research by providing highly specialized expertise and full
services for small animal imaging in a collaborative environment. A new PCC Shared Resource,
PCI was initially established at NYU School of Medicine (NYUSoM) in 2011 in response to the
growing demands for imaging instruments and additional imaging modalities by NYUSoM
biomedical research community. This was achieved by consolidating existing imaging
installations as part of the mouse imaging core successfully operated since 1997. Further
institutional investment led to the acquisition of additional scanners and to the diversification of
imaging modalities to serve NYU researchers, and in particular PCC investigators. Under the
expert direction of Dr. Yousseff Wadghiri, PCI provides rodent imaging modalities equivalent
to those available for human patients. The Specific Aims of PCI are: Aim 1) To provide expertise
in and access to small animal imaging, including MRI, PET/CT, ultrasound, bioluminescence
and fluorescence imaging; Aim 2) To provide technical assistance and training to all PCC
investigators using imaging modalities; Aim 3) To provide technical support for data analysis
and data sharing; Aim 4) To evaluate and implement novel imaging technologies and
modalities.